Molecular Principles Governing Mitochondrial and Peroxisomal Remodeling as Drivers of Cell Fate and Identity

SUMMARY
Background and key gaps in knowledge: Mitochondria serve as hubs coordinating diverse aspects of cellular
signaling, metabolism and inter-organelle dynamics. Our work during the ESI MIRA funding period has revealed
multiple roles for MCL-1, an anti-apoptotic BCL-2 protein, in the regulation of mitochondrial morphology and cell
state. Detailed mechanistic studies are still needed to understand this most basic aspect of MCL-1 function. The
non-apoptotic function of MCL-1 converges and relies on the mitochondrial dynamics machinery. The dynamic
nature of the mitochondrial network determines the ability of this organelle to regulate a variety of cellular
processes that are tightly linked to cell fate and identity. Mitochondria coordinate these functions by coordinated
remodeling, as well as by the physical and functional interaction with other organelles, such as peroxisomes,
which also undergo remodeling to coordinate their function. The critical need for controlled mitochondrial and
peroxisomal morphology in the maintenance of cellular homeostasis is highlighted by the wide spectrum of
neurodevelopmental diseases associated with mutations in the regulators of organelle dynamics. We will
combine our expertise in organelle and stem cell biology with state-of-the-art approaches to uncover the
mechanisms by which mitochondrial and peroxisomal dynamics maintain neurogenesis.
Description of recent progress by PI: In pluripotent stem cells, we reported that MCL-1 is required for
maintaining an apoptotic priming state and pluripotency through its regulation of mitochondrial morphology
(Rasmussen et al., 2018). In differentiated cells, we found that MCL-1 is also required to maintain cell identity
(Rasmussen et al., 2020; Cleveland et al., 2021). This function which is shared with other members of the BCL-
2 family (Joshi et al., 2020) requires the fine-tuned coordination with the mitochondrial dynamics machinery
(Rasmussen et al., 2018 and 2020; Joshi et al., 2020). The fundamental role of organelle remodeling in driving
cell fate determination, led us to examine the impact of abnormal mitochondrial and peroxisomal fission on
neurogenesis (Baum et al., 2020; Robertson et al., 2022, Robertson et al., 2023 in press), using an iPSC-based
discovery platform optimized to study organelle biology (Romero-Morales et al., 2019, 2022a, 2022b).
Overview of future research program: We propose to build upon our findings from the ESI MIRA by taking a
multi-faceted approach aimed at three areas: 1) Continue elucidating how MCL1 controls stem cell identity and
differentiation by regulating mitochondrial dynamics and metabolism. 2) Modeling the contribution of
mitochondrial and/or peroxisomal fission to cellular transitions during neuronal differentiation. 3) Finally, we will
identify the metabolic switches that are engaged by mitochondrial and peroxisomal remodeling during neuronal
differentiation. Detailed elucidation of these mechanisms will reveal connections between organelle dynamics
and cell fate as well as the relationship of these processes to the neuronal dysfunction associated with rare
mitochondrial and peroxisomal diseases.

Public health relevance
PROJECT NARRATIVE This project investigates the mechanisms by which mitochondrial and peroxisomal dynamics regulate cell fate and identity using induced pluripotent stem cell model systems. Through these efforts, we aim to uncover novel molecular principles by which mitochondrial and peroxisomal remodeling induce signaling and metabolic switches during cell transitions.